LA’s Biostatistics and Data Science Training Program (LA’s BeST)

ABSTRACT Health disparities in our nation are acute, increasing, and known to be caused by many factors. A multi- faceted approach by multi-disciplinary teams of scientists is needed to properly tackle this chronic and growing problem. Increasing the number of biomedical research scientists is one key strategy to address this crisis. With the current deluge of health-related data and a projected 34% growth in the job market for statisticians from 2019 to 2029 (Bureau of Labor Statistics), now is the time to increase our workforce in the specialties of biostatistics and data science. Herein, we plan to expand the pool of students in these disciplines by introducing a new curriculum for teaching critical skills in biostatistics and data science, LA’s Biostatistics and Data Science Summer Training Program at the University of Southern California (LA’s BeST @USC), with a focus on current research challenges in the study of heart and lung disease. The Division of Biostatistics in the Department of Preventive Medicine of the University of Southern California (USC) is uniquely positioned to attract talented undergraduates into these fields due to its success in graduate level training since 1976, its location in the populous LA Basin, its multi-disciplinary research, and real-life oriented approach to biomedical research. The faculty has expertise in ‘big data’, machine learning, epidemiological methods, spatial statistics and clinical trials, and has an NIH-funded P01 to develop novel statistical methods for integrative genomics. Training a modern workforce of scientists requires experienced faculty. A team of faculty who share a tradition of individual hands-on research mentorship and extensive portfolios of research grant support in biostatistics, epidemiology, clinical trials, and electronic health records, is amassed and available to trainees. With this team, we propose the following specific aims: 1) To identify and recruit high-quality and highly motivated college undergraduate students. 2) To provide the trainees with courses and hands-on training in biostatistics and data science. 3) To provide mentoring and professional development training. 4) To track LA’s BeST trainees through completion of their undergraduate degree, post-graduate education, and to their first employment.

Public health relevance
NARRATIVE Health disparities in our nation are acute and increasing the number of biomedical research scientists is one key strategy to address this crisis. With the current deluge of health-related data and a projected 34% growth in the job market for statisticians from 2019 to 2029 (Bureau of Labor Statistics), now is the time to increase our workforce in the specialties of biostatistics and data science. Herein, we plan to expand the pool of students in these disciplines by developing, conducting, and evaluating a summer course that teaches skills in biostatistics and data science, LA’s Biostatistics and Data Science Summer Training program at the University of Southern California (LA’s BeST @USC), with a focus on current research challenges in the study of heart and lung disease.